PERIPHERAL NOREPINEPHRINE STORE IN PHEOCHROMOCYTOMA

The ratio of plasma dehydroxyphenylglycol to norepinephrine (NE) levels will indicate whether or not exagerated neuronal release of NE occurs in patients with pheochromocytoma. COMPUTER ONLY.